IMMUNOCHEMICAL GENETICS OF MURINE ALLOANTIGENS

For the last several years our laboratory has been concerned with the biochemical genetics of cell surface antigens and with the immunogenetics of bone marrow engraftment. In this proposal, I outline planned research: 1) to analyze the genetics of bone marrow transplantation in mice. 2) to carry out studies on the genetics of beta 2 microglobulin in man by utilizing a restriction- fragment polymorphism of the B2M gene 3) to produce additional Qa/TL monoclonal antibodies 4) to use biochemical methods to study the array of B2M-associated molecules and 5) to analyze the expression of transfected Qa/T1a region genes.